Mass JCOIN II Clinical Research Hub

ABSTRACT
Our Justice Community Opioid Innovation Network Phase I Hub (MassJCOIN I) assessed the
implementation, substance use outcomes, and costs of pilot programs initiated in 2019 to provide all FDA-
approved forms of medication to treat opioid use disorder (MOUD) in seven Massachusetts (MA) county jails.
We found that only half of individuals who received MOUD in jail continued in the community after release.
Jails must strengthen transitional treatment during reentry to improve post-release MOUD continuity of
care. The federal Medicaid Inmate Exclusion Policy (MIEP), which removes Medicaid eligibility during
incarceration, is an obstacle to transitional treatment during community reentry. However, MA has received
federal approval for a MIEP waiver to restart MassHealth (i.e., Medicaid) coverage 90 days before release to
the community starting July 1, 2025 in 4 pilot jails (Franklin, Hampden, Middlesex, Suffolk) that deliver MOUD
and participated in MassJCOIN I. This policy change has the potential to improve transitional treatment for
individuals at high risk for post-release opioid overdose, although effective models of transitional care are
needed to optimize the impact of this policy innovation. Grounded in the Exploration, Preparation,
Implementation and Sustainment (EPIS) framework, our Aim 1 study will capitalize on existing MassJCOIN I
partnerships to study the implementation of the MIEP waiver to understand its impact on service delivery,
outcomes and costs of care for persons with OUD in the four pilot jails. Innovative cross-agency linked data
from the MA Public Health Data (PHD) warehouse will allow us to examine service utilization during the last 90
days of jail detention as well as the utilization and outcomes (e.g., MOUD initiation, engagement and retention,
and OOD) after jail release. Costing methodology developed in MassJCOIN I will estimate the potential
downstream cost-offsets with the MIEP waiver. For Aim 2, we will adapt an evidence-based manualized
cognitive behavioral therapy (CBT) intervention to a reach-in, telehealth format for community providers to
deliver to jailed, MIEP-waivered individuals on MOUD within 90 days before release and during community
transition. For Aim 3, we will test the adapted Reach-in CBT intervention in cluster-randomized, stepped
wedge clinical trial in which the Reach-in CBT will be sequentially rolled-out in the four pilot jails for residents
on MOUD whose MassHealth has been restarted and whose reentry plan includes a participating community
provider. We hypothesize that Reach-In CBT will enhance MOUD initiation, engagement and retention, and
reduce opioid overdose, reincarceration, and mortality over the 12 months post-release.
This project is significant and innovative because it will determine and disseminate best practices in MIEP
waiver implementation, as well as adapt and test a model of reach-in counseling to enhance MOUD continuity
at reentry. Findings will inform paradigm-shifting implementation efforts and services in MIEP waiver states.

Public health relevance
PROJECT NARRATIVE This study will determine and disseminate best practices in Medicaid Inmate Exclusion Policy (MIEP) waiver implementation in jails, as well as adapt and test a telehealth model of reach-in counseling to enhance medication for opioid use disorder (MOUD) continuity after release among persons who received MOUD in jail. Findings will inform paradigm-shifting implementation efforts and services in MIEP waiver states.